Circuitry- and cell-specific exploration of CB1R positive allosteric modulators in neuroHIV

Project Summary
Human immunodeficiency virus type 1 (HIV-1) currently affects over 38 million people worldwide. With combined
antiretroviral therapy (cART), HIV-1 is no longer a death sentence but a chronic disease with an inflammatory
component. HIV-1 virus enters the central nervous system (CNS) early in infection, and while cART effectively
suppresses viral replication in peripheral tissue, the CNS remains vulnerable. As cART does not cross the blood-
brain barrier, the prevalence of mild to moderate cognitive impairments, known as HIV-1-associated
neurocognitive disorders (HAND), remain high (50%). Brain regions specifically vulnerable to HIV include the
fronto-hippocampal system, involving deficits in learning and memory behaviors. The release of viral proteins
(i.e. Tat, Nef, gag) from HIV-1 infected brain resident cells plays a significant role in the underlying HAND
neuropathology, including lasting changes in neuronal excitability, inflammatory processes, and synaptic
communication. The endocannabinoid (eCB) system has attracted interest as a target for treating
neurodegenerative disorders due to its potential neuroprotective, anti-inflammatory, and neurotrophic properties.
However, due to psychoactive side effects, the therapeutic potential of cannabinoid type 1 receptor (CB1R)
agonists is limited. Therefore, efforts are now focused on alternative targets of the eCB system for its therapeutic
potential, including allosteric modulators. Published studies suggest that CB1R positive allosteric modulators
(PAMs), including ZCZ011, GAT229, and ABD1236, are promising candidates as they can enhance CB1R
activity indirectly without producing psychoactive effects, tolerance, or dependence. Additionally, as disease can
alter eCB signaling, the use of PAMs may help to compensate and return the CNS to its normal state. Our
preliminary data demonstrate neuroprotective effects of ZCZ011 against HIV-1 Tat-induced excitotoxicity as well
as improvement of recognition memory in HIV-1 Tat transgenic mice. GAT229 has been shown to reduce
behavioral signs and proinflammatory cytokines in rodent models of disease (e.g. neuropathic pain, Huntington’s
disease); and preliminary data for ABD1236 demonstrate enhanced eCB signaling. We will test an innovative
hypothesis that HIV-induced alterations in the mPFC→HPC neural circuitry predict deficits in mice performing a
working memory task, which can be prevented by positive allosteric modulation of the CB1R. To achieve this
goal, we will use well-established mouse models of neuroHIV/HIV and propose three aims. Aim 1 will determine
how CB1R PAMs alter neuronal activity in the mPFC→HPC neural circuitry in vivo of HIV-1 Tat transgenic mice
performing a working memory task. Aim 2 will determine the effects of HIV on eCB-mediated short-term synaptic
plasticity in the mPFC→HPC circuitry of HIV-1 Tat transgenic and EcoHIV-infected mice ex vivo. Aim 3 will
determine whether CB1R PAMs protective effects against EcoHIV-induced toxicity in vivo are mediated via
actions at CB1R-expressing glia or neurons. This work will provide a foundation for characterizing the role of
alternative targets of the eCB system in modulating memory circuitry in the context of HIV.

Public health relevance
Project Narrative The endocannabinoid system is known for its neuroprotective effects; however, direct activation of the cannabinoid type 1 receptor (CB1R) is undesirable due to its psychoactive side effects. By studying CB1R allosteric modulators, the proposed study aims to develop a novel therapeutic target for the treatment of HIV- associated neurocognitive disorders. We will test an innovative hypothesis that HIV-induced alterations in the mPFC→HPC neural circuitry predict deficits in mice performing a working memory task, which can be restored by positive allosteric modulation of the CB1R.